Selective Recruitment of RSK Protein Kinases Through Non-Catalytic Docking Interactions

ABSTRACT
Loss-of-function mutations in ribosomal protein S6 kinase 2 (RSK2, encoded by the RPSKA3 gene) cause Coffin-
Lowry syndrome, an X-linked dominant condition characterized by craniofacial abnormalities, short stature, and
intellectual disability. The RSK2 N-terminal catalytic domain (NTD) shares a consensus phosphorylation site
motif with numerous related kinases, including isoforms of AKT, SGK, and S6K. As such, it is difficult to
rationalize how RSK2 targets a unique substrate pool, and the utility of this target motif to discover substrates of
RSK2 and these other kinases is limited. Recently a cryptic allosteric pocket was identified in the RSK2 NTD
that binds to a short linear sequence motif found in several of its interacting proteins. This RSK-interacting motif
(RIM) consists of a core Val-Phe sequence, but the full motif has not yet been systematically defined.
Furthermore, it is not known whether the analogous binding site in other related kinases might target distinct
motifs. Here, we propose to comprehensively define RIM sequence space, screen the human proteome for
functional RSK2-interacting sequences, and determine whether other kinases utilize the analogous binding
pocket for protein-protein interactions. In preliminary studies, we have found the interaction between the RSK2
NTD and the RIM from its substrate protein SPRED2 is detectable by yeast two-hybrid (Y2H) analysis in a
manner sensitive to mutation of a core residue. To comprehensively define the RIM, we will construct a Y2H
double positional scanning library consisting of all pairwise combinations of residues at two positions in the
context of the SPRED2 sequence. We will screen the library against RSK2 and a panel of related kinases. We
will verify the importance of specific residues within the motif through quantitative measurements of kinase
binding to synthetic peptides harboring targeted substitutions. Guided by these results, we will construct and
screen a human proteomic Y2H library of candidate RIMs consisting of intrinsically disordered fragments of
human proteins. RSK2-interacting sequences identified from the screen will be validated as direct binders of
RSK2 in vitro. We will then investigate whether the full-length proteins harboring these sequences can act as
RSK2 substrates or interactors in a manner dependent on the docking motif. These results will form the basis
for subsequent in depth study of novel RSK2 substrates and their importance in normal physiology and in Coffin-
Lowry syndrome. Our studies may furthermore reveal that a large number of related protein kinases utilize the
corresponding interaction pocket in substrate docking, laying the groundwork for future studies to define their
interaction networks and better understand how they function.

Public health relevance
NARRATIVE A gene called RPS6KA3 is mutated in Coffin-Lowry syndrome, a condition that includes facial deformations, short stature, and intellectual disability. RPS6KA3 encodes the protein kinase RSK2, which regulates cellular responses to environmental cues. This research will identify protein substrates of RSK2 and reveal how it specifically targets these substrates and will therefore enhance our understanding of the roles of this kinase in normal physiology and disease.